Aortic Disease-Associated SNPs Lead to Epigenetic Regulation Alterations That Increase Susceptibility to Aortic Aneurysm and Dissection

Project Summary
Thoracic aortic aneurysms and dissections (TAAD) are life-threatening conditions for which
therapeutic options are limited. While genome-wide association studies (GWAS) have identified single
nucleotide polymorphisms (SNPs) associated with sporadic TAAD, the molecular mechanisms through
which these SNPs contribute to disease development remain unclear. The long-term objective of this
project is to elucidate the role of TAAD-associated SNPs in sporadic TAAD pathogenesis, with a focus
on their epigenetic and regulatory functions in aortic cells.
Recent research has shown that altered expression of extracellular matrix (ECM) and
inflammatory genes, and related epigenetic changes play critical roles in the progression of aortic
disease. Integrating GWAS data with single-cell chromatin accessibility (scATAC-seq) data from human
aortic tissues has revealed that many TAAD-associated SNPs are located within accessible chromatin
regions of aortic cells, suggesting that these SNPs influence regulatory elements activity.
This project tests the hypothesis that the risk alleles of TAAD-associated SNPs alter the binding
affinities of transcription factors (TFs), reshaping the local epigenetic landscape and driving target gene
dysregulation. The proposed research will systematically investigate the epigenetic mechanisms by
which sporadic TAAD-associated SNPs influence gene regulation. The first aim is to identify the
functional cell types where these SNPs exert their effects by integrating GWAS data with scATAC-seq
data to determine the cell types in which disease-associated SNPs are located within accessible
chromatin regions. The second aim focuses on exploring the epigenetic modifications and TF binding at
SNP-containing chromatin regions using integrative analyses of GWAS and CutRun-seq data, targeting
key histone modifications and TFs. The third aim will conduct allele-specific analyses by combining
whole-genome sequencing, scATAC-seq, and scRNA-seq data to determine the direct target genes of
SNPs in specific aortic cells.
By uncovering the functional and regulatory mechanisms of TAAD-associated SNPs, this study
will provide critical insights into the genetic and epigenetic basis of aortic disease, potentially leading to
new therapeutic strategies.

Public health relevance
Project Narrative The project aligns with the NIH's mission to improve understanding of disease mechanisms and contribute to the development of innovative approaches for diagnosis and treatment of vascular diseases. Completion of this study will significantly improve our knowledge of the molecular mechanisms underlying aortic aneurysms and dissections, with the potential to lead to the identification of novel diagnostic markers and the development of therapeutic strategies.